Factors Impacting Global Health: The Importance of Individualized Treatment Goals for Black Breast Cancer Survivors

This F31 award will allow Kelsey Sinclair (PI) the research training that will advance her toward her goal of becoming an independent cancer multimorbidity scientist with an expertise in intervention adaptation and implementation to optimize cancer care in underserved groups. Cancer-obesity co-morbidity is common and especially deadly for Black breast cancer survivors (BCS). Although Black women have lower breast cancer incidence, they have the highest breast cancer mortality rate (40%) of any U.S. race/ethnic group – an effect attributed to comorbid obesity. Obesity predicts higher mortality among Black BCS, and post-cancer diagnosis weight gain predicts increases in mortality. One way to fight back against the effects of obesity is to develop and to deliver obesity treatments adapted to address the unique challenges of the BCS community. Identification of important risk/protective factors can be applied to evidence-based weight loss interventions to provide potentially life-extending care. The proposed multi-method study will use a socioeconomic framework and multi-methods to discover actual risk/protective factors for Black BCS with obesity compared to other BCS. PI Sinclair will leverage resources from a parent trial to first use a quantitative survey to assess 100 BCS from any race-ethnicity to test potential risk and protective factors that differ for Black BCS (Phase 1). Second, using co-design qualitative methods, initial tailoring of an evidence-based weight loss intervention for obesity will be done in collaboration with our patient partners – five Black BCS with obesity (Phase 2). This tailored weight loss protocol will then be delivered in a pilot with 15 Black BCS with obesity, with preliminary evaluation of potential treatment heterogeneity factors (Phase 3). Via these phases, the following F31 aims will be addressed: Aim 1: To proactively identify lifestyle and multimorbid factors of an obesity intervention for Black BCS and Exploratory Aim 2: To explore obesity treatment response in Black BCS via subgroup analyses. The proposed F31 will thus utilize Phase 1 survey data and Phase 2 qualitative interviews (Aim 1) as well as Phase 3 post-treatment data (Exploratory Aim 2). Accordingly, it will benefit from the existing parent pilot infrastructure (e.g., recruitment strategies, participants, trial conduct). For the parent trial, the outcomes are acceptability, feasibility, and preliminary weight loss of the program. PI Sinclair’s project and training plan will allow for a comprehensive multi-method analysis of adaptation factors to inform future larger-scale trials and foundations of a future F32 or K23 for PI Sinclair, a future scholar with expertise in multimorbidity interventions in cancer, obesity, and other chronic diseases differently impacting breast cancer survivors.

Public health relevance
Black breast cancer survivors with obesity are at an increased risk of poorer cancer-related outcomes, additional multimorbid conditions, and worse survival/greater mortality. This innovative multi-method study will identify protective and risk factors needed to tailor evidence-based weight loss interventions to address the unique challenges of Black breast cancer survivors – which will contribute to vital scientific and public health knowledge regarding intervention design for a population at high risk. Further, this project will serve as a valuable training opportunity for a young scholar to gain expertise in multimorbidity among underserved populations and how to adapt interventions targeting multimorbidity to advance cancer care and treatment.